Mitochondrial and Cellular Biomarkers of Renal Injury from Environmental and Therapeutic Agents

Abstract:
Exposure to a broad range of environmental contaminants, including halogenated solvents, polycyclic aromatic
hydrocarbons, and heavy metals, can cause kidney injury. Acute kidney injury (AKI) is also a dose-limiting side
effect of several classes of therapeutic drugs, including many antibiotics, antiviral agents, anticancer
chemotherapeutic agents, and NSAIDs. Although some highly sensitive protein biomarkers have been
validated in recent years, they are still associated with some degree of renal damage. Markers that can
indicate exposure yet be detected prior to any or after only minimal injury are preferable. Additionally,
identification of new markers that are more closely linked to mechanism of action will enhance understanding
of mechanism and improve therapeutics. Our approach to identification of such mechanistic markers has
focused primarily on the mitochondria as common, early, and sensitive targets in proximal tubular cells for an
array of environmental contaminants and therapeutic drugs. We will use primary cultures of proximal tubular
cells from human kidneys (hPT cells) as the experimental model system. Our overall hypothesis is that
exposure of hPT cells to environmentally or therapeutically relevant concentrations of toxicants or therapeutic
agents, respectively, will modify mitochondria and other cellular components and result in release of selected
proteins and lipids and altered patterns of metabolites. Although association of mitochondrial dysfunction with
various forms of kidney injury and disease is well-established, our application of this central, underlying
concept to identify mechanistically-based biomarkers is novel. hPT cells will be treated with two environmental
contaminants (the trichloroethylene metabolite S-(1,2-dichlorovinyl)-L-cysteine [DCVC] and HgCl2) or three
therapeutic agents (tenofovir disoproxil fumarate, cisplatin, and polymyxin B) that all target renal mitochondria.
Additionally, antimycin A will be used as a positive control. Preliminary studies helped refine the hypothesis
and identified three specific proteins, one mitochondrial (sulfite oxidase), one cytoskeletal (keratins), and one
cytoplasmic (HSP90), as potential biomarkers and take a targeted approach for validation. Specific Aim 1 will
take a targeted approach to determine the utility of released proteins from hPT cells as biomarkers. We will test
whether release of mitochondrial sulfite oxidase, cytoskeletal keratins, and cytoplasmic HSP90 reflect
exposure to and proximal tubular toxicity from nephrotoxicants. Release of proteins will be correlated with
parameters of renal cell function and viability and other well-established biomarkers. Specific Aim 2 will focus
on modified (adducted or oxidized) proteins in hPT cells as biomarkers. Specific Aim 3 will focus on release of
cardiolipins, other lipids, and intermediary metabolites as sensitive indicators of exposure to and proximal
tubular toxicity from nephrotoxicants. Finally, Specific Aim 4 will focus on the potential identification of proteins
in exposomes, including those identified in Aims 1 and 2, as another potential source of sensitive markers of
exposure and injury.

Public health relevance
Project Narrative: The kidneys are frequent targets of both environmental contaminants and several classes of therapeutic agents that exhibit dose-limiting nephrotoxicity. We will use primary cultures of proximal tubular cells from fresh human kidneys in targeted studies to identify protein, lipid, and low-molecular- weight metabolite patterns that are associated with exposure to a diverse array of nephrotoxic chemicals. We anticipate validating biomarkers that are linked to chemical mechanism of action, are specific and highly sensitive, and correspond to exposure prior to or after onset of only minimal renal injury.